CAMPO Administrative and Coordinating Core

The overall goal of this study is to assess the effectiveness of different recruitment strategies, including health professionals trained in patient navigation services and CTs, in the recruitment of PLWH for the ULACNet-101, the first of three CTs under the CAMPO Consortium, PR site